Testing the effectiveness of an evidence-based transdiagnostic cognitive behavioral therapy approach for improving HIV treatment outcomes among violence-affected and virally unsuppressed women in SA

Project Summary
There are currently just under one million people with HIV in South Africa who have initiated antiretroviral
therapy (ART) but remain unsuppressed. South Africa has been making progress towards UNAIDS 90-90-90
targets but has only reached 47% of those infected being virally suppressed. Therefore, if effective approaches
can be found to keep patients on treatment, adhering, and virally suppressed, the impact could be significant.
In South Africa, one major barrier to consistent treatment is intimate partner violence (IPV) as nearly 50% of
women have experienced IPV. Addressing IPV could have effects in supporting patients on HIV treatment to
continue to adhere. The Common Elements Treatment Approach (CETA) is an evidence-based intervention
comprised of cognitive-behavioral therapy elements. It is transdiagnostic in that it can flexibly address a range
of problems and represents the current movement in global mental health as a more cost effective, scalable
and sustainable model. CETA is one of the most promising interventions to impact HIV outcomes through
addressing violence
To evaluate CETA, we propose a randomized controlled trial of HIV-infected women, with or without
their partners, who have experienced IPV and have an unsuppressed viral load to test the effect of CETA on
increasing viral suppression and reducing violence. The study has three aims: Aim 1: Among HIV-infected
women on ART who have experienced IPV and have an unsuppressed viral load, to assess the effectiveness
of CETA vs. active control at increasing the proportion retained and virally suppressed by 12 months and at
decreasing the severity of IPV and other mental and behavioral health problems using an individually
randomized trial. Aim 2: To identify mediators and moderators of CETA’s effect on the primary outcome
(retention and viral suppression). Aim 3: To assess the cost and cost-effectiveness of CETA vs. active control
at increasing the proportion of women who have experienced IPV who are retained and virally suppressed by
12 months.
The study question is significant given the prevalence of IPV in female patients with unsuppressed
viral loads in South Africa and the potential for improving viral suppression by addressing IPV and its sequelae.
If effective, this approach could have a significant global impact on outcomes for virally unsuppressed
women and reduce transmission to uninfected partners. It is innovative in utilizing an evidence-based
approach (CETA) shown to affect IPV as well as many other problems that contribute to poor HIV treatment
outcomes.

Public health relevance
Project Narrative This study will evaluate the impact of the Common Elements Treatment Approach (CETA), an evidence-based intervention comprised of cognitive-behavioral therapy elements, at improving HIV treatment outcomes among women with HIV who have experienced intimate partner violence (IPV) and have an unsuppressed viral load on HIV treatment. To evaluate CETA, we will conduct a randomized controlled trial of HIV-infected women, with or without their partners, who have experienced IPV and have an unsuppressed viral load to test the effect of CETA in increasing viral suppression and reducing violence. We will also identify mediators and moderators of CETA’s effect on retention and viral suppression and assess the cost and cost-effectiveness of CETA vs. active control at increasing the proportion who are retained and virally suppressed by 12 months.